Interactions of Leptin and Central Serotonin Systems

DESCRIPTION (provided by applicant): The increasing incidence of obesity is a major health issue facing the USA. Fortunately, in the past decade several key hormones and central nervous system (CNS) pathways controlling body weight and glucose homeostasis have been identified. Indeed, we now have a rough CNS roadmap through which key metabolic signals like leptin exert their effects. This may lead to effective strategies to combat the incidence of obesity, diabetes and eating disorders. In the past grant period, we found that CNS serotonin (5-HT) systems interact with hypothalamic melanocortin neurons. We created a reactivatable 2C null mouse model, and we found that re-expression of 5-HT2CR only in pro-opiomelanocortin (POMC) neurons rescues hyperphagia, obesity and insulin resistance caused by global deletion of 5-HT2CR. However, our studies thus far have not determined if there are other physiologically important targets of serotonin receptor agonists. In the current proposal we will extend these observations using several mouse models in which we can selectively reactivate or delete the 5- HT2CR in specific subsets of neurons. We will determine if neurons in the paraventricular nucleus of hypothalamus are sufficient to restore the anorexigenic properties of 5-HT2CR in the 2C null mice. We will also determine if 5-HT2CR re-expression by key autonomic regulatory neurons in the brainstem is sufficient for normal body weight and glucose homeostasis. Finally, we will determine if autonomic preganglionic neurons expressing melanocortin 4 receptors mediate the anti-diabetic actions of serotonin receptor agonists.

Public health relevance
PUBLIC HEALTH RELEVANCE: Obesity is now recognized as global crisis due to its increasing prevalence and serious comorbidities, including insulin resistance and diabetes. Understanding the homeostatic mechanisms that maintain normal body weight and glucose balance and looking for rational targets for anti-obesity and anti-diabetic therapies are a priority in the field. The proposed research will investigate the efficacy of central serotonin system in the regulation of food intake, body weight and glucose homeostasis and will identify critical brain sites that mediate the anti-obesity and anti-diabetic effects of serotoninergic compounds. Results from these studies will advance our understanding of the serotoninergic circuits necessary to permit the design of effective treatment strategies for obesity and diabetes. REVELANCE STATEMENT Obesity is now recognized as global crisis due to its increasing prevalence and serious comorbidities, including insulin resistance and diabetes. Understanding the homeostatic mechanisms that maintain normal body weight and glucose balance and looking for rational targets for anti-obesity and anti-diabetic therapies are a priority in the field. The proposed research will investigate the efficacy of central serotonin system in the regulation of food intake, body weight and glucose homeostasis and will identify critical brain sites that mediate the anti-obesity and anti-diabetic effects of serotoninergic compounds. Results from these studies will advance our understanding of the serotoninergic circuits necessary to permit the design of effective treatment strategies for obesity and diabetes. __SpecificAimsTextDelimiter__ SPECIFIC AIMS: Coordinated control of energy and glucose balance is required to sustain life. However, aberrant food intake and impaired glycemic control are prevalent. Indeed, the increasing incidence of obesity and diabetes is a major health issue facing western societies. Central serotonin systems play critical roles in the regulation of feeding and glucose balance. Drugs influencing 5-HT bioavailability such as d-fenfluramine (d-Fen) and sibutramine are among the most potent appetite suppressants. Recent findings indicate that d-Fen and meta- chlorophenylpiperazine (mCPP, a 5-HT2CR agonist)improve glucose profile in obese mice1-2. However, due to the presence of fourteen 5-HT receptor isoforms and their wide distribution in the brain3, discerning mechanisms underlying functions of 5-HT compounds has proven particularly difficult. Taking advantage of a unique "reactivatable" 2C null mouse model we made, we have generated mice with 5-HT2CRs only expressed in pro-opiomelanocortin (POMC) neurons. Characterization of these mice has identified POMC neurons as one physiologically relevant target of 5-HT compounds (e.g. d-Fen) to suppress food intake 4. However, neuroanatomy and pharmacological data suggested that other 5-HT2CR sites in the brain may provide redundant mechanisms to mediate the anorexigenic effects of 5-HT compounds. For example, neurons in the paraventricular nucleus of the hypothalamus (PVH) receive serotoninergic input from raphe nuclei in the brainstem5-6 and 5-HT2CR mRNA is expressed in the PVH7-10. 5-HT2CR agonists activate PVH neurons, an effect blocked by 5-HT2CR antagonists10-15. In addition, infusion of 5-HT receptor agonists into the PVH suppresses food intake16-21. In addition, 5-HT2CR mRNA is expressed by brainstem autonomic control neurons including those in the tractussolitarius(NTS) and the parasympathetic preganglionic neurons in the dorsal motor nuclues of the vagus (DMV)7-10. These neurons are also activated by 5-HT1,12,22-23.Notably, infusion of d-Fen and mCPP into the 4th ventricle induces anorexigenic responses similar to those produced by systematic administration of these compounds24-25. In the past grant period we found that 5-HT2CRs expressed by POMC neurons regulate insulin sensitivity and glucose production in the liver. Consistently, mCPP improves insulin sensitivity and glucose tolerance in wildtype mice with diet-induced obesity. In contract, the anti-diabetic effects are blunted in mice lacking melanocortin 4 receptors (MC4Rs)1. Collectively, these results indicate that the centralmelanocortin system mediates effects of 5-HT2CRson glucose regulation. However, the critical MC4R sites that mediate effects of 5-HT2CRson insulin sensitivity and glucose balance remain to be identified. Using a "reativatable" MC4R null mice we made in the lab, we recently found that restoration of MC4Rs in the cholinergic (ChAT) neurons partially rescues the hyperglycemia and hyperinsulinemia charateristic of MC4R null mice. Hypothesis I: 5-HT2CRsexpressed in the PVH or by neurons in brainstem autonomic regions contribute to the regulation of energy and glucose homeostastis. This hypothesis will be directly tested in Aims 1 and 2. Specific Aim1:To determine if selective restoration of 5-HT2CRs in PVH SIM1 neuronsis sufficient to rescue metabolic alterations caused by global deletion of 5-HT2CRs. Specific Aim 2: To determine if selective restoration of 5-HT2CRs in brainstem Phox2b neurons is suffcient to rescue metabolic alterations caused by global deletion of 5-HT2CRs. Hypothesis II: MC4Rs expressed by cholinergic autonomic preganglionic neurons mediate the effects of 5- HT compounds to regulate insulin sensitivity and heptic glucose production. Specific Aim 3: To determine if selective restoration of MC4Rs in cholinergic neurons is sufficient to mediate anti-diabetic effects of 5-HT compounds in diet-induced obese mice. The 5-HT2CR is an attractive target for the treatment of obesity and diabetes26. Indeed, activation of this receptor largely explains the appetite suppressing effects of d-Fen27, a drug that was widely used to combat obesity in the 1990s. However, the critical CNS sites where 5-HT2CRs regulate feeding behavior and glucose homeostasis are not fully understood. The experiments proposed in this application will use unique mouse models to systematically explore the physiological significance of 5-HT2CRs in several neural populations and its downstream MC4R sites in the context of metabolic control. Results from these experiments willincrease the understanding of the serotoninergic circuits necessary to permit the design of effective treatment strategies for obesity and diabetes. In addition, the proposed research represents another step in our comprehensive program using conditional, neuron-specific gene targeting methods to identify important genes and CNS circuits that are required to maintain energy balance.